Genetic control of neural stem cell homeostasis

Neural stem cell (NSC) homeostasis represents a state of delicate equilibrium between self-renewal, differentiation,
and survival. It is fundamental to the development, growth, and regeneration of the nervous system. Defects in NSC
homeostasis underlie broad neurodevelopmental, psychiatric, and neurodegenerative disorders. The mechanisms
underlying the control of NSC homeostasis remain incompletely understood. Drosophila has been instrumental in
discovering signaling molecules such as Notch and Numb and cellular mechanisms such as asymmetric cell division
that are centrally involved in NSC homeostasis. The Drosophila larval brain type II neuroblasts (NBs) have served as
an excellent model for studying NSC homeostasis. Similar to mammalian NSCs in lineage hierarchy, the type II NB
lineages in the Drosophila larval brain contain transit-amplifying intermediate progenitors (IPs), which can generate a
vast number of differentiated progenies. Notch signaling is critical for maintaining the homeostasis of type II NB
lineages. Inhibition of Notch signaling results in NB not being properly maintained, whereas Notch hyperactivation
causes ectopic NB formation and brain tumorigenesis. Notch signaling also regulates the homeostasis of mammalian
NSCs, with deregulated Notch signaling having been linked to brain cancer. The molecular mechanisms by which
Notch signaling regulates NSC homeostasis, however, are not well delineated. Previous studies have focused heavily
on canonical Notch signaling mediated by transcription factors acting in the nucleus. We have found that a non-
canonical Notch signaling (NNS) pathway operating in the cytosol and involving mitochondria critically mediates Notch
function in NSC homeostasis. The clinical significance of this NNS pathway is underscored by our observation that
tumor-initiating cancer stem cells (CSCs) are particularly sensitive to perturbation of this pathway. Moreover, we found
that this NNS pathway exerts co-translational quality control over a master regulator of cell growth. The goal of this
proposal is to move away from the status quo of transcriptional control of NSC behavior by Notch and focus on the
newly discovered co-translational quality control mechanism by NNS signaling. Our central hypothesis is that non-
canonical N signaling regulates NSC homeostasis through a signaling cascade emanating from mitochondria and
impinging on the ribosome-associated quality control (RQC) of a master regulator of cell growth. To test this
hypothesis, we propose three integrated Specific Aims. Aim 1 will characterize features of the translation of the growth
regulator that necessitates RQC. Aim 2 will examine the functional relationship between a key RQC factor and this
growth regulator in NSCs and CSCs. Aim 3 will dissect the molecular mechanism by which mitochondrial activity
signals to the RQC machinery to regulate the translation of the growth regulator. Upon successful completion of these
Aims, we will have generated new mechanistic insights into the control of NSC homeostasis by Notch. We anticipate
that this will open entirely new directions for studying the fundamental roles of Notch in NSC and cancer biology.

Public health relevance
Project Narrative Maintaining homeostasis of the neural stem cell pool is fundamental to the development and integrity of the nervous system. By providing insights into the mechanism of how the evolutionarily conserved Notch signaling pathway acts in a non-canonical manner to regulate neural stem cell homeostasis, this study has the potential to lead to deeper understanding of the development and maintenance of the nervous system and inform the development of novel therapy for brain tumors and a range of neurological conditions where altered Notch signaling has been implicated.